Modeling age-specific computational strategies during reward seeking

PROJECT SUMMARY (See instructions):
The neuronal circuitry underlying motivational processes in adolescent models is understudied but clinically
relevant because disorders such as depression, schizophrenia, and substance use disorder, which are
marked by alterations in motivation, emerge during adolescence. The frontal cortex and striatum are critical
targets because they are amongst the last regions to mature. My previous work investigated how
orbitofrontal cortex (OFC)-dorsomedial (DMS) circuits guide goal-directed processes and control response
inhibition in adolescent and adult rats. Additionally, I investigated the impact of adolescent alcohol
exposure on these networks. I found that adolescent alcohol exposure is associated with age-specific
changes in OFC and DMS response to conditioned stimuli and reward. In a separate study, I recorded from
dopamine neurons and observed that adolescents exhibited a larger phasic response to reward in a
stimulus-driven task, while adults exhibit a larger response when reward is acquired during a goal-driven
task. Collectively, these data suggest adolescent alcohol exposure promotes lasting changes in OFC-DMS
circuits, and that adolescents and adults employ different computational strategies during reward-seeking,
likely due to age-specific activity in cortical-striatal circuits. The proposed projects use a combination of
computational modeling, chemogenetics and in vivo electrophysiology recordings to test the hypotheses
that (1) developmental maturation is characterized by an enhanced ability to employ goal-directed control
of behavior and (2) adolescent alcohol exposure causes pathology in neural circuits required for goaldirected control. These experiments will further elucidate the relationship between goal-directed processes,
adolescent alcohol exposure and risk of addiction-related behaviors. Using previously acquired recordings
of the OFC and DMS in adult and adolescent rats (K99), I will integrate experimental and computational
approaches to model neural strategies underlying motivated behavior in adolescents and adults (Aim 1).
Next, I will use chemogenetics to test the model predictions and determine causality between behavior and
physiology (Aim 2). Lastly, I will determine how engagement of different computational strategies is
impacted by adolescent alcohol exposure (Aim 3). These translational results will enhance our mechanistic
and computational understanding of adolescent brain function which is fundamental for understanding the
etiology and pathophysiology of disorders with an adolescent onset, such as addiction.

Public health relevance
RELEVANCE (See instructions): Little is known regarding the neural circuitry responsible for reward seeking behaviors in adolescence. However, adolescence is characterized by an increased motivation to seek reward and is a time period where several mental disorders characterized by alterations in motivational processes emerge. The proposed projects seek to investigate how adolescent and adult brains differentially influence reward behaviors and the impact of adolescent alcohol drinking on brain function and behavior.